Noise-induced vestibular-mediated motor impairment and restorative therapies

Balance, gait, agility, and related sensory disorders affect millions of Americans and are among the most
common service-related disabilities. Despite the impact of vestibular associated disorders on such large
portion of the general public and Veterans, there remain challenges to effective detection and diagnosis. Due
to their anatomical proximity to the cochlea and shared fluid pathway, the vestibular portion of the inner ear,
particularly the saccule and utricle, is exposed to sound pressure and is at risk for noise overstimulation.
There is now evidence that noise contributes to vestibular dysfunction, however understanding of
underlying mechanisms and thus the available treatments and rehabilitative strategies are limited. Our
previous studies in the rat model have shown that noise exposure causes pathological changes that lead to
significant decreases in vestibular short latency evoked potential (VsEP) responses and loss of calretinin
immunoreactivity of calyx-only afferent terminals, resulting in vestibular hypofunction (VH) (Stewart et al., 2018,
2020a, 2021) and impaired motor performance (Bartikofsky et al., 2023). The proposed studies will assess the
cumulative impact of continuous and impulse noise exposures that are commonly encountered during service,
explore functional consequences of peripheral vestibular injury, and evaluate treatment with 7,8-
dihydroxyflavone, a compound that treats peripheral vestibular damage.
The proposed studies will increase our understanding of how Military-relevant continuous and impulse
noise exposures cumulatively damage the vestibular periphery and examine how and why some vestibular
associated functions recover when VH persists. Specifically, we will explore vestibular-mediated dynamic
motor performance in the absence of sensory reweighting that may increase reliance on vision after vestibular
injury by using a dark condition that removes visual information in a balance beam crossing task. Although our
data suggest that continuous noise exerts the most significant impact on the saccule and utricle, it is known
that impulse noise also produces a measurable impact on semicircular canal cristae function. We will explore
this impact and the impact of continuous noise exposure on head (vestibulocollic reflex) and eye movement
(vestibulo-ocular reflex) using on- and off-axis rotary stimulation. We will correlate measured deficits with
changes in VsEP and with cellular changes in vestibular end organs. We will also test treatment with 7,8-
dihydroxyflavone, a compound that acts on tyrosine receptor kinase B receptors, similar to brain-derived
neurotrophic factor, and has shown promise in the vestibular system to determine if this compound restores
vestibular function after noise exposure.
Due to their significant noise exposure histories and higher risk for VH due to service-related noise
exposures, this work is of particular relevance to Veterans. Development of restorative therapies will hold
significant clinical relevance for Veterans, who incur cumulative damage to the vestibular periphery over time
and might not experience the consequences of noise exposure until this damage reaches a critical level.
Identifying, addressing, and treating VH will ensure Veterans receive accurate diagnoses and interventions that
increase independence and quality of life by preserving mobility and preventing fall risk. Studying vestibular-
mediated mobility issues in rats will allow us to identify markers of VH that contribute to falls in compensated
Veterans that may otherwise have a missed diagnosis. Results of this work will provide data that will guide
rehabilitative treatments that enhance visual compensation and restorative therapies that deal with mobility
issues when visual compensation is not possible. The results of the proposed studies will provide clinical
impact for Veterans (1) by characterizing the progression of VH due to repeated exposure to noise, (2) by
evaluating behavioral changes associated with cumulative peripheral vestibular damage, (3) by testing a
promising compound with the potential to improve rehabilitation.

Public health relevance
Relevance of the Proposed Work to the VA Patient Care Mission. Noise-induced hearing loss is the most common service-connected condition in Veterans. Noise also produces measurable damage and dysfunction in the vestibular periphery which may lead to postural instability and compromised balance. Although this partially compensates with vision and proprioception, when these systems are compromised due to aging, injury, or disease, risk for falls that may lead to serious injury or death is increased, leading to reduced quality of life. Understanding how different types of noise impact the vestibular periphery leading to dysfunction will provide the basis for developing treatments that provide functional recovery for Veterans with a history of noise exposure and improve their quality of life. This first goal of this project is to investigate how commonly encountered noise exposures cumulatively damage the inner ear leading to motor impairment. The second goal is to restore vestibular function with a promising new compound that may lead to functional rehabilitation.